Meaning-Centered Psychotherapy to Meet Palliative Care Needs of Cancer Caregivers

PROJECT SUMMARY
In 2020, 53 million people in the U.S. served as family caregivers, the partners, relatives, and friends who
provide assistance (i.e., physical, emotional) to patients with often life-threatening, incurable illnesses.
Caregivers are increasingly tasked with responsibilities once performed by medical professionals, and the
availability and health of supportive caregivers is more critical than ever. A growing number of caregivers
provide care to patients with advanced, life-limiting cancers, and are tasked with critical patient care
responsibilities, and play a significant role in healthcare communication and advanced care planning as
healthcare proxies. The burden of these responsibilities is great and is driven largely by existential distress,
which contributes to anxiety, depression, poor quality of life, and mental health challenges in bereavement.
Concurrently, caregiving is an opportunity to experience a profound sense of meaning and purpose; caregiving
allows for the realization of new strengths and capacities, healing of relationships, and refinement of life goals.
When existential distress is addressed, caregivers can experience an enhanced sense of well-being despite
their challenges. While many interventions have been developed to support cancer caregivers, none directly
target existential distress. Our group adapted Meaning-Centered Psychotherapy (MCP), a highly effective
intervention in decreasing existential distress and enhancing well-being among patients with advanced cancer,
for cancer caregivers. Meaning-Centered Psychotherapy for Cancer Caregivers (MCP-C) is a stakeholder-
informed, innovative, manualized intervention designed to assist caregivers to connect to meaning and
purpose in life, despite the challenges of caregiving. Results of our pilot randomized controlled demonstrated
MCP-C’s feasibility, acceptability, and superiority in improving meaning, benefit-finding, depression, and
spiritual wellbeing. In the proposed trial, we will more rigorously evaluate the efficacy of MCP-C through a
randomized controlled trial of 200 caregivers of patients with advanced (Stage III/IV solid tumor) cancer who
will receive 7 sessions of MCP-C or Supportive Psychotherapy for Caregivers (SP-C), the standard of
community-based caregiver care. Participants will undergo assessments of meaning and spiritual wellbeing
(primary outcomes), and anxiety, depression, benefit finding, caregiver burden, and social support (secondary
outcomes) at baseline, post-treatment, and at 6- and 12-months follow-up. Bereavement outcomes including
pre- and post-loss grief, preparedness for loss, and regret will also be evaluated at each time point. We predict
MCP-C will result in greater improvements in primary and secondary outcomes, and that sense of meaning in
life will mediate treatment effects. We also predict that MCP-C will result in better preparedness for loss and
improved pre- and post-loss grief and regret. Our results will enhance our capacity to powerfully target
existential distress in caregivers of patients with advance cancer and by extension, improve their capacity to
provide critical care to patients at end-of-life.

Public health relevance
PROJECT NARRATIVE The increasingly crucial role played by family and friend caregivers of patients with advanced cancer is complicated by existential distress, but to date, current psychosocial interventions fail to address such distress. This project is relevant to NIH’s mission as it represents a critical step in the refinement of a targeted intervention–Meaning-Centered Psychotherapy for Cancer Caregivers (MCP-C)–that has shown encouraging results in improving caregivers’ sense of meaning in life and spiritual wellbeing and ameliorating anxiety and depression. If successful, MCP-C holds significant promise to not only improve the quality of life for caregivers across the caregiving trajectory from diagnosis through bereavement, but also to yield downstream benefits to the patients for whom they provide care.